The Interplay of Mesenchymal Stem Cells and Neutrophils During Rapid Maxillary Expansion

PROJECT SUMMARY
This K08 proposal outlines a five-year research career development program focused on
elucidating the biological role of mesenchymal stem cells (MSCs) and their interaction with
neutrophils during mid-palatal suture expansion/distraction osteogenesis. The candidate is an
instructor in the Department of Orthodontics at Penn Dental Medicine. Building on previous
research and clinical experience in addressing transverse problems in orthodontic treatment, this
proposal aims to equip the candidate with multidisciplinary skills essential for transitioning to an
independent clinician-scientist with expertise in stem cell biology and osteoimmunology.
Clinically, patients with maxillary transverse deficiency (MTD) exhibit varied responses to
rapid maxillary expansion (RME), which is often more challenging in opening the mid-palatal
suture in skeletally mature patients. While new techniques such as TAD-supported or surgical-
assisted RME improve expansion efficacy, the biological basis underlying RME remains unclear,
particularly concerning cell populations and tissue heterogeneity within the mid-palatal suture and
the molecular mechanisms responding to mechanical forces during suture distraction
osteogenesis. Preliminary studies have identified Gli1+ MSCs within mouse mid-palatal sutures,
showing their proliferation in response to the RME mice model. The advent of large-scale single-
cell RNA sequencing (scRNA-seq) technique has significantly advanced our ability to analyze cell
heterogeneity in complex tissues. Osteoimmunology, which highlights the interaction between
bone and immune systems, extends our research scope to immune cells, revealing their
predominance in mid-palatal cell populations. Notably, neutrophils actively respond to mechanical
stimuli, suggesting that MSCs and the immune microenvironment potentially influence RME
efficacy. The aims of this proposal are: (1) To investigate the role of Gli1+ MSCs in response to
mechanical stimuli during mid-palatal suture distraction osteogenesis, and (2) To identify the
transcriptomic signatures of various cell populations in mouse mid-palatal suture, elucidating the
interplay between MSCs and neutrophils during RME. This work may uncover previously
unrecognized immune-MSC modulatory targets for maxillary expansion/distraction osteogenesis,
paving the way for molecular modulation of suture growth and improved patient management,
including identifying an immune molecular target that enhances mid-palatal suture growth with or
without orthopedic approaches.

Public health relevance
PROJECT NARRATIVE Patients with maxillary transverse deficiency (MTD) demonstrate varied responses to rapid maxillary expansion (RME), which is often more challenging in opening the mid-palatal suture in skeletally mature individuals. This study aims to elucidate the biological role of mesenchymal stem cells (MSCs) and investigate their interaction with neutrophils during maxillary expansion/distraction osteogenesis. By uncovering previously unrecognized immune-MSC modulatory targets, this proposal could pave the way for molecular modulation in RME and suture growth, leading to improved patient management.